Modulation of intracellular lipid access by ATGL determines ferroptosis sensitivity in castration-resistant prostate cancer

Project Summary
Prostate cancer (PCa) is the second most common cancer-related mortality cause in American males.
Although therapies targeting androgen receptors are generally effective in treating advanced PCa, no curative
treatments currently exist for castration-resistant prostate cancer (CRPC). Recent research reveals CRPC’s
vulnerabilities to oxidative stress due to its unique metabolic reprogramming. This elevated susceptibility creates
an environment favorable for a form of cell death called ferroptosis. Ferroptosis is brought about by the
intracellular accumulation of toxic lipid hydroperoxides. Hence, ferroptosis induction represents a promising
novel therapeutic approach for drug-resistant cancers. Despite increased sensitivity to ferroptosis, CRPC
manages to avert this cellular fate. In this proposal, we have identified a key enzyme involved in lipid metabolism,
adipose triglyceride lipase (ATGL), that engenders metastatic castration-resistant prostate cancer cells with the
ability to resist ferroptosis. Our preliminary data demonstrates that ATGL facilitates prostate cancer growth,
migration, and invasion. In CRPC cell lines, ATGL deletion sensitizes prostate cancer cells to ferroptosis, likely
through regulating the GPX4-mediated ferroptotic control pathway. However, the exact mechanism linking
ferroptosis and ATGL in CRPC is unknown. Moreover, while ferroptosis inducers (FINs) are hopeful candidates
for anticancer agents under development, their use for treatment and how to enhance their efficacy remains
underexplored in CRPC. Our central hypothesis is that ATGL promotes the resistance of CRPC to ferroptosis
inducers in an oxidizable lipid-dependent manner.
Therefore, Aim 1, the F99 phase, is designed to (1) identify the underlying mechanisms by which ATGL
modulates the regulatory pathways that lead to ferroptosis, and (2) evaluate the efficacy of a combined therapy
employing FINs, ATGL inhibitors, and anti-androgens as well as investigate the underlying mechanisms behind
the observed synergy between anti-androgens and ferroptosis inducers in the context of ATGL ablation. Dr.
Daniel Frigo, Ph.D., in the Department of Cancer Systems Imaging at MD Anderson Cancer Center is the primary
sponsor of this F99 phase. Aim 2, the K00 phase, is to demonstrate the role of ATGL’s transacylation activity
and its product, fatty acid esters of hydroxy fatty acid (FAHFA) in prostate cancer. Considering the K00 proposal
focuses on metabolism and cancer progression, it will be conducted at a laboratory that excels in these fields.
The fulfillment of these aims holds promise to deepen our knowledge of cancer biology and guide the
development of innovative complementary therapeutic approaches that enhance the effectiveness of anti-
androgens, thus improving the clinical outcomes of patients suffering from advanced prostate cancer.
The proposal also contains a training plan that details further scientific, technical, and professional
training. The plan is formulated to ensure the successful completion of the project and a smooth transition to a
future career as an independent investigator.

Public health relevance
Project Narrative Existing therapies for advanced prostate cancer, including androgen deprivation therapy and chemotherapy, remain insufficient once patients acquire resistance, thus resulting in unsatisfactory long-term survival outcomes for patients harboring aggressive or metastatic disease. By identifying a key enzyme involved in lipid metabolism, known as adipose triglyceride lipase (ATGL), that engenders metastatic castration-resistant prostate cancer with the ability to resist ferroptotic cell death, this F99/K00 proposal aims to 1) determine the underlying biology driving the synergy between ATGL inhibition and ferroptosis inducers- an emerging class of remarkably potent cancer therapeutics, 2) examine the safety and efficacy of novel ATGL-directed combination therapies, and 3) identify potential biomarkers of ATGL and ferroptosis that could guide future therapeutic applications. The success of this proposal could pave the way for novel treatment regimens that are highly effective in patients with lethal prostate cancer, thus improving the quality of life for prostate cancer survivors.